Core 2: Biostatistics/Bioinformatics Shared Resource

The involvement of skilled biostatisticians and bioinformaticians is critical for the success of research in the basic and translational sciences. Research aimed at addressing cancer burden associated with variations in incidence and outcomes is no exception. For this reason, a Biostatistics and Bioinformatics Shared Resource (BBSR) is an integral part of this Morehouse School of Medicine/Tuskegee University and the University of Alabama at Birmingham O’Neal Comprehensive Cancer Center Partnership. For full/pilot projects, outreach, research education and planning and evaluation activities, the BBSR provides consultation and collaborative support regarding study design, and statistical and bioinformatics analyses. The BBSR also assists in the development of grant proposals, abstracts, and manuscripts. In addition to its work supporting the research of Partnership investigators, the BBSR's support enhances the biostatistical and bioinformatics capabilities of the Partnership institutions. This is accomplished by providing guidance to junior investigators and scholars at all levels regarding sound applications of statistics and bioinformatics principles in cancer research. The BBSR also participates in the Research Education Programs of the Partnership through the Research Education Core.

Public health relevance
The Biostatistics and Bioinformatics Shared Resource (BBSR) will lead efforts to support the data analysis needs of investigators across the MSM/TU/UAB OCCC Partnership. The BBSR will provide centralized, comprehensive, state-of-the-art support to ensure scientific rigor and reproducibility in the development and execution of the Partnership’s cancer research projects and programs.